Mechanisms of pathology and neuronal hyperactivity in a memory circuit in Alzheimer's disease

Previous work from the Tsai lab (Canter et al 2019) identified the mamillary body (MB) as one of
the first sites of amyloid deposition in 5XFAD model mice, a region that also correlates with
dementia severity in human patients. Single cell RNA sequencing of the mouse MB identified 2
distinct neuronal populations within the MB, with segregated distribution, target projection, and
unique electrophysiology. Analysis of these populations in the 5XFAD mice found that one of
these populations, those found in the lateral MB (LM), are uniquely susceptible to hyperactivity
and neurodegeneration, while the second population (medial MB, MM) is largely unaffected.
The activity of the LM population also directly contributes to mouse performance in memory
tasks. Additionally, using iterative direct-expansion microscopy (idExM) from the Boyden lab, we
have identified intriguing patterns of amyloid associated with specific projections in the fornix,
the white matter tract from the subiculum with axonal inputs to the MB. This grant proposes to
investigate the links between amyloid and excitability changes in the MB and fornix, including
development of the tools necessary to achieve this goal. The hypothesis to be tested in this
application is that amyloid preferentially associates with the subiculum-LM projection and that
these axons exhibit hyperexcitability. Aim 1 will map the connections between this new
population of LM neurons and its upstream inputs from the hippocampus, using a newly
developed in situ sequencing techniques, as well as exploring pathology in the white matter
projection regions of this circuit in 5XFAD mice and human brain samples, using recently
developed expansion microscopy. Aim 2 will characterize the source and location of
hyperactivity found in the LM neurons through advanced voltage imaging, as well as expand this
work to other mouse models of AD. Aim 3 will use optogenetics and pharmacological
approaches to determine if specific aberrant circuit activity drives the pathology and behavioral
changes seen in the AD model mice.

Public health relevance
The Papez circuit consists of several extra-hippocampal structures, which, although thought to be necessary for memory, are much less studied in Alzheimer’s disease. Recent work from our lab indicates that specific neurons in the mammillary body (MB) are preferentially affected in AD, particularly in terms of hyperactivity, but how these neurons are connected in the circuit, and what the cause and the long-term effects of the hyperactivity of these specific neurons are not known. We will use cutting-edge neuroscience techniques developed in our group to investigate the important aspects of this memory circuit in AD.